Neural Probe for high spatial and temporal resolution detection of cocaine and su

DESCRIPTION (provided by applicant): The specific aim of this proposal is to test the feasibility of developing a long-lasting, implantable probe for rapid measurement of multiple neurochemicals in the brain. Currently, neuroscience research is limited to three techniques for measuring the concentrations of neurochemicals in vivo; microdialysis to obtain average concentrations over a relatively long time period (5-20 minutes), enzyme-based biosensors to detect a single neurochemical every second over a relatively large spatial area (500 μm length electrode), and carbon-fiber microelectrodes to detect dopamine with fast scan cyclic voltammetry (FSCV). A new tool is required for rapid detection of concentrations of multiple neurochemicals with spatial resolution on the cellular level. Such a tool would allow neuroscience researchers to ask new questions about the mechanisms behind disease states and behaviors, such as drug consumption. The proposed neural probe fulfills this need by detecting two neurochemicals every 4 seconds with 50 μm spatial resolution. The proposed probe will detect cocaine and substance P, a neuropeptide implied in cocaine addiction (Kampman, 2010). In 2008, reports stated that 1.4 million Americans meet the criteria for abuse or dependence on cocaine, which is associated with violence and incarceration (NIDA 2010; Nyamathi et al., 2012). SB Microsystems has already developed a proprietary MEMS process for fabricating implantable, multi-site neural probes for studying the rat brain. Our existing probes have the feature size necessary for a 10-fold spatial resolution improvement over the available enzyme-based electrodes. The proposed probe will build on our existing platform by functionalizing the probe site surfaces with molecules for the detection of specific neurochemicals. Detection of multiple neurochemicals will be achieved by patterning different neurochemical- specific detection molecules onto adjacent probe sites. Our Phase I proposal will determine feasibility for commercialization of these probes by; 1) improving functionalized probe fabrication by adjusting aptamer molecule modifications, immobilization technique, and electrical signal detection to achieve the best possible sensitivity and time response and 2) developing a Potentiostat circuit based for detection. Next, we will 3) functionalize the probe to detect multiple analytes with the cocaine and substance P aptamers and 4) implant probes into rats for in vivo data collection. Success in this Phase I feasibility study will be determined by te accurate detection of physiologically relevant concentrations of cocaine and substance P by probes that are stable in vivo for 2 days. In Phase II, we plan to develop more aptamers that can be applied to our probes for the detection of more than 2 neurotransmitters. We will use principles of robust design to turn our prototype into a commercial product. The attached letters of support indicate that we may be able to sell a successful prototype from Phase I to neuroscience researchers.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed work will result in a tool that can be used to study the brain mechanisms behind disease states such as Parkinson's disease, and behaviors such as drug consumption and dependence. Through the rapid detection of multiple neurochemicals, this product can provide more detailed information than currently available neuroscience tools. SB Microsystems is an engineering services firm with experience in the field of neuroscience tools and has the expertise required to produce robust, commercially viable implantable biosensors for neuroscience and clinical applications. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The specific aim of this proposal is to test the feasibility of developing an implantable probe for rapid measurement of multiple neurochemicals on the cellular scale in the brain. The ability to follow changes in the brain is extremely important to our understanding of brain function for therapeutic opportunities. The proposed probe's ability to rapidly detect multiple chemicals in a live, behaving animal may lead to an improved understanding of acute changes in neurochemicals that occur over several seconds. Such data could reveal unstudied mechanisms behind disease states like seizures, or behaviors like drug consumption, that were previously obscured by the low temporal resolution of current methods. The high spatial resolution of the proposed probe allows for chemical detection around small groups of neurons, which helps to isolate the endogenous activity of different neuron types. For example, studying dopamine-producing neurons and their role in Parkinson's disease has been used to develop a neuron transplant therapy (Mendez et al., 2005). Neurochemical detection can also be used to measure tissue response to exogenous stimuli, such as pharmacodynamics of drugs (Hargreaves and Costello, 1990). The proposed probe will detect cocaine and substance P, a neuropeptide implied in cocaine addiction (Kampman, 2010). The high temporal and spatial resolutions and multi-neurochemical sensing of the proposed probe will allow for detailed studies on in vivo brain response to both endogenous and exogenous stimuli. To the best of our knowledge, none of the currently available methods for neurochemical quantification (microdialysis, enzyme-based biosensors, or carbon-fiber microelectrode FSCV) is able to detect chemicals with both the temporal and spatial resolution of the proposed probe. Microdialysis measures concentrations over a 2-20 minute collection period, resulting in average neurochemical measurements that obscure concentration changes associated with particular behaviors (Wilson and Gifford, 2005). Even when collected over a short time period, the accuracy of microdialysis measurements is largely diminished by factors (flow rate, percent recovery etc.) that must be accounted for when converting analyte to in vivo concentrations (Griffin et al., 2009). Enzyme-based biosensors can detect neurochemicals such as ethanol, glutamate, and dopamine with a 1-20 second response time (Oldenziel et al., 2004), but have poor spatial resolution (0.5 - 1.0 mm) and can only detect one analyte per electrode (Behrend et al., 2009). Additionally, no enzyme-based sensor is available for substance P or cocaine detection. Finally, carbon-fiber electrode FSCV is able to collect dopamine, adenosine, and ascorbate concentrations with ms time response, but cannot reliably detect multiple chemicals simultaneously (Heinen et al, 2004). Additionally, FSCV electrodes are only viable for 90 s - 30 min of in vivo data collection (Perry et al., 2010; Hermans et al., 2008). Our proposed sensor will have 50 μm spatial resolution between detection sites and a time response of <4 seconds, allowing it to detect multiple neurochemicals on the cellular level in response to brief behavioral events, such as lever pressing in decision-making experiments. We will accomplish our Specific Aim by carrying out the following tasks: Task 1: Improve functionalized probe fabrication Task 2: Develop a potentiostat circuit for signal detection Task 3: Fabricate probes for multi-chemical detection Task 4: Test in vivo probe sensing capabilities The test of feasibility will be the achievement of 1) a 48-hour in vivo probe lifespan, 2) time resolution for data collection <4 seconds, 3) the limit of detection of neurochemical concentrations down to 0.1 μM and 1.0 μM for substance P and cocaine, respectively (Brownstein et al., 1976; Hurd et al., 1988), and 4) the ability to simultaneously detect substance P and cocaine on sites that are 50 μm apart. In Phase II, we will develop probes to detect three or more neurochemicals and develop custom aptamers for use in vivo to detect target molecules. Robust design principles will be applied to produce a commercial product, including a telemetry system provided by DSI (see letter of support). Company: SB Microsystems is an engineering services firm that provides designing, prototyping and testing services in biomedical research, technology development, and commercialization. We have developed products such as a chip for cell sorting (Layton et al., 2012) and a neural probe for optogenetics experiment (Jamieson and Mateo, 2011). The proposed probes will cost approximately the same as our current neural probes ($300), the cost of which is comparable to setting up a microdialysis experiment. SB Microsystems has filed for a provisional patent on our technology and plan to file for a full patent within the year.